ENDOTHELIAL FUNCTION IN HUMANS FOLLOWING A HIGH FAT MEAL

This protocol will test the effect of hypertriglyceridemia on endothelial function. Endothelial function will be assessed using intra-arterial infusions of pharmacologic agents combined with measurement of forearm blood flow in healthy subjects.